Somatic variants as drivers of genetic errors of immunity

Project Summary – Project 2
The diagnosis of the precise genetic cause and mechanism of inborn errors of immunity (IEI) has led to enhanced
care and treatment of patients through improved diagnosis, guidance for clinical monitoring based on genotype,
and targeted therapies. However, at least 60-70% of patients with suspected IEI lack a molecular diagnosis. The
goal of this project is to address the gap in diagnosis through detection and validation of mosaic genetic variants
in patients with suspected IEI. The current standard for clinical and research-based testing for IEI is exome and
genome sequencing to identify germline changes in genes encoding proteins relevant to the immune response.
However, it is now becoming well recognized that IEI can also arise from somatic mosaicism, which, although
not inborn, lead to genetic errors of immunity (GEI). Such somatic mutations in GEI lead to a dominant effect,
whereby a minor population of immune cells alters the immune response leading to clinical disease. Consistent
with this dominant phenotype, immune dysregulation disorders account for most known cases of disease-
causing somatic mosaicism in GEI. Somatic mutations can also alter disease phenotype, accounting for a high
degree of variable penetrance within families. These somatic mutations can be missed by current genomic
sequencing approaches due to insufficient depth of coverage with exome and genome sequencing, as well as
the informatic challenges in detecting true mosaicism versus sequencing artifact. Thus, current challenges when
working to identify disease-causing somatic mosaicism in GEI include the need for high read-depth sequencing
and algorithms to discern low-frequency mosaicism from sequencing artifact, which is particularly important for
GEI in which there are no ‘tumor’ and ‘control’ samples within an individual. We present preliminary studies using
high-depth targeted sequencing of genes associated with or predicted to be associated with GEI with an immune
dysregulation phenotype. Our studies demonstrate the presence of somatic mutations in the targeted genes in
at least 12% of undiagnosed patients. In this project, we will utilize an expanded custom sequencing platform to
investigate the rate and presence of somatic mosaicism in ~2000 patients with suspected GEI, and a cohort of
currently healthy individuals. We will use this data to identify potentially disease-causing variants that will be
investigated at the single-cell level to determine their impact on the immune system and expressivity of the
identified variants. This project will be supported by Cores A and B of this Program and will benefit from
collaboration and sharing with the other projects of this P01. The ability to recognize and accurately diagnose
somatic mosaicism in GEI has high potential to alter the care of these patients.